ROLE OF OVARIAN HORMONES AND PARATHYROID HORMONE IN BONE METABOLISM

The aims of this study are to determine 1) if PTH can prevent hypogonadism induced bone loss 2) to study the effect of long-term subcutaneous PTH administration in young people 3) to investigate the roles of ovarian hormones on PTH and vitamin D metabolism.